Mechanisms of White-Opaque Switching in Candida albicans

Project Summary/Abstract
Candida albicans is one of the most prevalent fungal pathogen of humans and also a component of
the human microbiome; it can cause superficial infections in normal humans and life-threatening
systemic infections in immune compromised individuals. Our work seeks to understand how C.
albicans regulates its genes so it can survive and proliferate in the many different environments of its
human host. This proposal focuses on a single, large transcription circuit—the white-opaque switching
circuit—which allows two different cell-types to be produced epigenetically from the same genome.
White-opaque switching is deeply conserved across clinical isolates of C. albicans and is also
observed in closely related Candida species. This proposal seeks to understand the mechanism
behind white-opaque switching, the mechanisms underlying the stability of the two distinct, epigenetic
cell-types and the effects of white-opaque switching on Candida’s ability to thrive in its mammalian
hosts.

Public health relevance
Project Narrative The yeast Candida albicans is a normal resident of the human digestive tract and also one of the most common fungal pathogens of humans, causing both mucosal and systemic infections, particularly in immune compromised patients. This proposal seeks to understand how a deeply-conserved feature of Candida albicans—white-opaque switching—occurs in mechanistic terms and how it contributes to Candida’s ability to infect mammals. White-opaque switching enables two very different types of cells—each of which is stable through many rounds of cell division—to be produced from the same genome.